Objective Mobile diagnostics for Optic Neuropathies

Diseases of the afferent visual system are central to the practice of neuro-ophthalmology (N-O). Visual function
often dictates type of treatment, but screening exams are a burden on already stretched neuro-ophthalmic clinics.
Therefore, there is an unmet need for a practical, rapid, sensitive test that is objective and provides
quantitative functional endpoints for early diagnosis and monitoring response to newly developed
treatments for neuro-ophthalmic diseases.
NeuroFieldz has developed NeuroVEP, a breakthrough portable wireless sensor system with a new technique
called Electric Field Encephalography, measuring visual evoked potentials (VEP) at the visual cortex in response
to custom visual stimulus patterns presented on a head mounted smartphone display. Neuroelectric recordings
are analyzed for full-field stimulus (ffVEP) and 62 sectors of the visual field (multi-focal, mfVEP). Extensive
previous development has resulted in a near final prototype validated with 200+ case studies in macular
degeneration, glaucoma, multiple sclerosis (MS) and optical neuritis. A pilot study of ON / MS patients
demonstrated the superiority of the NeuroVEP system over a conventional wired clinical system in terms of
portability and ease of use, superior VEP results, in addition to providing mfVEP visual field results.
Hypothesis and Objective We hypothesize that ffVEP and mfVEP analysis using the NeuroVEP, when
accurately targeted, measured, and analyzed, can provide detailed objective neuro-ophthalmic diagnostic
information on neurovisual impairments associated with diseases of the afferent visual system. This Phase I
SBIR project aims to conduct a feasibility study for the use of the NeuroVEP system for diagnosis and staging
of N-O diseases. Specific Aim 1: Develop custom tests for ON and validate on 100 normal subjects and
100 patients. Task 1: Paradigm development of 62 sector background pattern-onset VEP and validation on 100
naïve normal subjects (200 eyes). Task 2: mfVEP validation using synthetic defects with blocked sectors. Task
3: Test-retest to verify repeatability. Task 4: Acquire NeuroVEP test results on 100 N-O subjects (200 eyes)
diagnosed with diseases of the afferent visual system. Subjects will undertake a battery of tests including patient
consenting, ff/mfVEP using NeuroVEP, corrected visual acuity (Snellen), AP and OCT. Specific Aim 2: Machine
learning based analysis of VEP signals and develop a diagnostic analysis score for staging neuro-
ophthalmic diseases. Obtain multiple metrics including 6 parameters for ffVEP and >22 features for
mfVEP including latency and amplitude of P100 for each individual eye and calculating inter-ocular and inter-
hemisphere latency differences and amplitude ratios from the ff/mfVEP results. Extract additional distinguishing
metrics using advanced signal processing methods including discrete wavelet transform for classification
criteria to distinguish between normal, early and late stage N-O subjects. The ff/mfVEP results will be
correlated with AP, OCT, and clinical variables using comprehensive multi-variate statistical analysis for a
complete validation of NeuroVEP.

Public health relevance
PROJECT NARRATIVE TITLE: Objective Mobile Diagnostics for Neuro-Ophthalmology This project seeks to develop a new portable wireless system called NeuroVEP that combines a sensor for measurement of scalp electric potentials and fields in response to visual stimuli presented by a virtual reality headset powered by a smartphone, and to test them in patients with neuro-ophthalmic diseases. NeuroVEP will address an unmet need for a practical, sensitive test that will provide quantitative endpoints for early diagnosis and monitoring response to newly developed treatments for neuro-ophthalmic diseases.